Career Enhancement Program (CEP)

Project Summary/Abstract
The Career Enhancement Program (CEP) exists to identify, support, and mentor candidates with promising
independent careers in translational brain tumor research. The CEP also represents an opportunity to
encourage new and established non-translational investigators, including women and under-represented
minorities (URM), to consider careers in translational brain tumor research. In this manner the program
ultimately serves to expand translational brain tumor research, as well as a source of translational projects and
investigators for the SPORE Program itself. The Specific Aims of the UCSF Brain Tumor SPORE CEP are: 1.
To identify, support, and mentor individuals with promising careers in translational brain tumor research 2. To
encourage new and established investigators to develop careers in translational brain tumor research. 3. To
encourage women and URM candidates to develop independent careers in translational brain tumor research.

Public health relevance
Project Narrative The Career Enhancement Program is required component of all SPOREs and must be maintained for the entire funding period. The UCSF Brain Tumor SPORE commits $100,000 per year to the CEP in support of research that facilitates the goals of the program. Another $50,000 per year is provided by funds from the UCSF Department of Neurological Surgery through the Helen Diller Family Comprehensive Cancer Center (HDFCCC), allowing the SPORE to fund up to three CEP projects per year